Administrative Core

The Administrative Core will provide infrastructure to facilitate the research in the PPG. To achieve this goal, the following specific aims have been identified: 1. Provide administrative support for the Program Project Grant activities. 2. Direct the PPG budgetary and financial support. 3. Promote interactions between the Pis, co-PIs, Project Leaders, Core Directors, and other professional personnel involved in the PPG. 4. Facilitate the transfer of research materials between investigators. 5. Assure proper oversight of research goals of the PPG

Public health relevance
RELEVANCE (See instructions): Core A will provide the administrative support for the Program Project grant, including management of the budget, interactions between Project Leaders; transfer of research materials between Projects and Cores, and compliance of the research program.